NanoDiscs for Immune Modulation in Celiac Disease

PROJECT SUMMARY/ABSTRACT
Celiac disease (CeD) affects approximately 1% of the global population, with gluten exposure leading to
symptoms such as nausea, vomiting, and damage to the small intestine. Although a lifelong gluten-free diet is
the current standard of care, strict adherence is challenging, and disease symptoms may persist despite
compliance. This underscores the urgent need for novel therapeutic strategies.
We are developing an interdisciplinary bioengineered platform focused on nanotechnology for targeted drug
delivery in CeD. Our research emphasizes the formulation, manufacturing, and in vivo investigation of synthetic
high-density lipoprotein NanoDiscs. These NanoDiscs are designed for controlled release of peptide antigens
directly to lymph nodes. In preclinical studies, NanoDiscs have demonstrated strong potential for promoting
immune tolerance in various murine models, including CeD.
Additionally, our pre-IND meeting with the FDA has provided valuable feedback on our manufacturing plans,
clinical trial design for CeD, and the required preclinical dataset for IND submission, guiding our research
strategy. Building on these promising preclinical results and regulatory insights, we propose to advance
NanoDiscs as a novel therapeutic solution for CeD. By leveraging biomaterials, nanotechnology, and advanced
drug delivery systems, our research aims to address the unmet needs in CeD treatment and provide patients
with more effective therapeutic options. This approach could also pave the way for new strategies in treating
other conditions requiring targeted delivery of therapeutic agents.

Public health relevance
PROJECT NARRATIVE The objective of this project is to develop NanoDiscs as a tolerogenic vaccine platform and advance a proof-of- concept application in Celiac disease (CeD), a condition for which no approved therapies currently exist. The cornerstone of CeD management is lifelong adherence to a strict gluten-free diet (GFD). However, maintaining a GFD is challenging, costly, and may not fully alleviate disease symptoms. This proposed research aims to create a novel vaccine-like strategy for treating CeD, potentially opening avenues for treating other autoimmune diseases and leading to new strategies for achieving disease control.